HIV & Aging SWG

Project Summary/Abstract (HIV and Aging Scientific Working Group)
The long-term objectives of the Miami-CFAR HIV and Aging Scientific Working Group (HA-SWG) are to promote
innovative and emerging areas of research in HIV and aging through multidisciplinary collaborations. Since its
inception in February 2019, the HA-SWG is actively involved in research on mechanisms that address the
specific challenges that significantly impact our HIV-infected aging population in South Florida and beyond. Our
studies include evaluation of HIV-related comorbidities and immune dysfunction and their influence on frailty and
cognitive decline. The overall theme of multi-morbidity research serves to broaden the potential and scope of
our SWG. In this application, we are presenting a significantly modified SWG that was developed with a focus
on knowledge-based activities through the creation of working groups. These groups will study specific research
areas utilizing innovative approaches. The topic of metabolic regulation of the immune system in aging is under-
investigated and how HIV infection interacts with age-related metabolic reprogramming of immune cells and its
implications on the earlier onset of immune dysfunction and comorbidities demands further investigation. Our
current approach to understand the physical and cognitive frailty in aging persons living with HIV (PWH) has
translational relevance. The HA-SWG will further expand the scope of research in this area by investigating the
role of the gut-brain axis and liver-brain axis in the processes of neuroinflammation, accelerated neurocognitive
decline and cognitive frailty in aging PWH. Here we propose two specific aims of the HA-SWG. First, to develop
and promote innovative cross-disciplinary and collaborative translational research in the areas of immunology,
metabolic regulation, neuroinflammation, frailty and cardiovascular/liver co-morbidities. Second, we will develop
educational and mentoring activities within the University of Miami (UM) scientific community while enhancing
the research goals specified in Aim 1. By achieving these aims, the HA-SWG endeavors to create a platform for
interdisciplinary research at UM by bridging the clinical challenges of frailty, cognitive decline and comorbidities.
These efforts will also support basic science research studying the mechanisms underlying metabolic regulation
of immunity in HIV and Aging. The HA-SWG is also committed to create a resource-rich infrastructure to support
cross-disciplinary proposals related to HIV and aging, support Early Stage Investigators and researchers new to
the field of HIV research. To achieve our goals, the HA-SWG is uniquely positioned to leverage clinical and basic
research resources and expertise available to the Miami-CFAR and infrastructure available at UM through the
McKnight Brain Institute, Center on Neurocognitive Science and Aging, Comprehensive Center on Brain Health,
Clinical and Translational Science Institute, Diabetes Research Institute, Schiff Center for Liver Diseases and
Sylvester Comprehensive Cancer Center.